Project BrEAtHe (Brothers, Reclaiming, Emotional, Awareness, Tranquility, Healing & Ex-istence): Disrupting Racism-related Stress, Trauma, & Problematic Substance Use in Young Adult Black Men

PROJECT SUMMARY/ABSTRACT
COVID-19 and upticks in U.S. racialized violence are stealing our collective breaths and brewing a potent mix,
or syndemic of stress, trauma, and negative affect – key risk factors for behavioral health disparities.
Behavioral health disparities among Black males are well-documented and known to erupt during young
adulthood (ages 18-29) when this population exhibits steep escalations in problematic substance use (e.g.,
marijuana and alcohol). Many young adult Black males also reside in disadvantaged neighborhoods settings
with conditions like high violence, alcohol, and other drug activity linked to substance use. While we know that
Black males residing in disadvantaged neighborhoods are disproportionately impacted by racism (i.e., racial
profiling by police and citizens) and that racism is a risk for self-medicating with alcohol and marijuana, few
substance use interventions have been adapted to target this culturally-relevant stressor or related trauma
symptoms. Mindfulness-based stress reduction (MBSR) interventions featuring meditation and breathing space
training have been shown to reduce maladaptive stress response, trauma symptoms, and substance use,
principally by improving self-regulation (i.e., affect and physiological). Yet, a fundamental lag exists in the
cultural adaptation of established MBSR interventions and exploration of new modalities for delivering them to
Black males. As a result, less is known about their feasibility, acceptability, or probable effectiveness in this
disparity population. Successful MBSR interventions require participant home practice and deployment of
acquired skills in real-world settings. Integrating mobile technologies, especially ones providing ‘real-time’
feedback, could further enhance MBSR interventions’ impacts on substance use mitigation among young adult
Black males by providing supportive nudges in moments and settings when racism-related stress and trauma
symptoms likely peak. Adapted, mobile technology-assisted MBSR interventions will likely be more acceptable
by young adult Black males when they are developed with their input and address culturally relevant stress,
trauma, and the gender norms (e.g., boys don’t cry) often encouraging males to regulate negative affect by
pushing it out of conscious awareness. Our theory-driven central hypothesis, is that preventive interventions
aimed at modulating racism-related stress response, trauma symptoms, and affect regulation especially in
‘real-time’ will reduce problematic substance use progression among young adult Black males. This R34
application proposes the following aims to be carried out among 18-29 year-old Black males in Durham, NC
and Hartford, CT – settings with strikingly similar neighborhood disadvantage: 1) To culturally adapt a validated
instructor-led, group-based and mobile technology-assisted, MBSR intervention; 2) To pilot test and assess the
feasibility/acceptability of a culturally adapted instructor-led, group-based and mobile technology-assisted,
MBSR intervention; 3) To identify preliminary effect sizes and mediators to determine sample size and power
for a larger fully scaled mobile technology-assisted, instructor-led, group-based MBSR intervention.

Public health relevance
PROJECT NARRATIVE The proposed “Project BrEAtHe (Brothers, Reclaiming, Emotional, Awareness, Tranquility, Healing & Ex-istence): Disrupting Racism-related stress, Trauma, & Problematic Substance Use in Young Adult Black Men” will culturally adapt, and assess the feasibility and acceptability of a validated instructor-led, group-based mobile technology-assisted, mindfulness-based stress reduction intervention. Co-led by the University of Connecticut Health Disparities Institute (HDI) and University of North Carolina-Chapel Hill, the study aims to modulate racism-related stress response (e.g., physiological), trauma symptomatology, and affect regulation associated with problematic substance use among young adult Black males in disadvantaged urban and urban-rural neighborhoods. This study will advance substance abuse prevention science, mitigate progression to problematic substance use, and ultimately reduce substance use-related morbidity and mortality among young adult Black males.